An Engineered Bioprinting Platform to Study Neural Migration in Assembloids

Neural organoids represent a powerful tool for modeling the brain and neurodevelopmental disorders (NDDs),
but they are unable to capture the interactions between distinct brain regions, which are critical for later brain
development. To capture these important interactions, our team established a novel modular brain organoid
system, termed brain assembloids, in which organoids of separate brain regions are combined in a single culture.
Using these assembloids, we demonstrated that Timothy syndrome, a rare genetic condition affecting cognitive
function, is associated with defects in GABAergic interneuron migration. A key limitation of this new technology
is that current assembloid protocols require manual positioning of organoids within liquid media, resulting in poor
reproducibility and lack of physiologically-relevant brain geometries and connectivities, while making more
complex assembloids (i.e., of 3 or more organoid types) prohibitively laborious. Additionally, individual organoid
building blocks are commonly cultured in either Matrigel, a poorly defined, highly variable derivative of mouse
sarcoma cells, or as free-floating suspensions, which commonly result in unwanted organoid fusion. This results
in high variability of organoid size and quality within and between batches. Here, we propose a novel
bioengineering platform to enhance the quality, reproducibility, and complexity of neural assembloids
to strengthen their use as physiologically- and spatially-relevant in vitro models of interneuron migration
in neurodevelopment and NDDs. We leverage a novel magnetic 3D-bioprinting technology (termed SPOT) to
generate assembloids of precisely-controlled spatial orientation, constructing physiologically relevant neural
connections, and using well-defined biocompatible polymers to enhance reproducibility in organoid and
assembloid size and quality. In Aim 1, we begin by evaluating the hypothesis that increasing the viscosity of the
surrounding medium will improve the size and organizational reproducibility of brain organoids from several
distinct regions that resemble a mid-gestation developmental stage: cerebral cortex (hCO), medial ganglionic
eminence (MGE)-like subpallium (hSO), and lateral ganglionic eminence (LGE)-like striatum (hStrO). We will
use SPOT to print two-part assembloids of various combinations and evaluate interneuron migration and cortical
neuron projections. In Aim 2, we will use SPOT to print three-part assembloids with precise spatial positioning
between the MGE-, LGE-, and cortex-like organoids. We hypothesize that reproducible control over geometric
positioning of the individual organoids will significantly improve the reliability of interneuron path-finding, allowing
this human microphysiological system to be used for NDD studies. In Aim 3, we leverage our three-part
assembloids to study the effects of several NDD-related genes on interneuron migration and validate the utility
of our bioengineered platform. This transformational work will provide an advanced platform for the controlled
construction of complex assembloids, enabling unprecedented molecular and functional studies into human brain
development and diseases.

Public health relevance
Human induced pluripotent stem cell (hiPSC)-derived neural assembloids represent a powerful tool to study neural interactions across multiple brain regions; unfortunately, current assembloid generation protocols commonly yield randomly oriented, heterogeneous structures with limited spatial control, which significantly limits their application in functional studies. We propose to develop a novel, non-destructive 3D-bioprinting technology to pattern reproducible, precise, and spatially-relevant, assembloid structures as in vitro models for studying interneuron migration in neurodevelopment and its disorders. The success of our work will establish a transformational technology that yields robust and reproducible assembloids for in vitro functional investigations into human brain development and diseases, with proof of concept studies targeting autism spectrum disorder.